Genetic and epigenetic architecture of natural telomere length variation

Project Summary
Telomeres are evolutionarily conserved protein-DNA complexes at the physical ends of
linear eukaryotic chromosomes. Telomeres shorten with age in most human somatic cells, and
their initial length pre-determines cellular lifespan. Mutations in telomere maintenance genes
lead to cancer, premature aging and a number of age-related disorders. While mean telomere
length in humans shows considerable inter-individual variation and appears to be under strong
genetic control, the exact nature of factors establishing telomere length set point remains
elusive. Using the model plant Arabidopsis thaliana, we previously identified several candidate
genes underlying natural telomere length variation in this species. In this proposal, we will utilize
genetic, genomic, biochemical and epigenetic approaches to explore their functions in telomere
length control and other major cellular processes, and to gain an evolutionary perspective on
functional gene pleiotropy. In Aim 1, we will explore several hypotheses for direct and indirect
roles of Arabidopsis TERT gene, which encodes the catalytic subunit of telomerase, in
establishing natural telomere length polymorphism across Arabidopsis genotypes. We will also
employ powerful Arabidopsis genomic and transcriptomic tools to identify and characterize TERT
trans-regulators and uncover novel factors underlying natural variation in telomerase enzyme
activity levels across multiple Arabidopsis genotypes. Through a series of genetic
complementation experiments with Arabidopsis telomere length mutants, experiments in Aim 2
will address the nature and extent of functional redundancies between telomere biology,
ribosome biogenesis and chromatin assembly, and establish the blueprint for dissecting
telomeric versus non-telomeric roles of identified genes. Additionally, in Aim 2 we will utilize
several innovative genomic and epigenetic approaches to identify and validate additional
candidate genes involved in telomere length control. Overall, the results of this study are
expected to significantly increase our understanding of genetic differences underlying telomere
length polymorphism in natural Arabidopsis populations. Because modes of telomere regulation
are highly conserved, our data may also provide novel insight into the molecular basis for
different rates of aging and predisposition to human diseases associated with telomere length
abnormalities.

Public health relevance
Project Narrative: Telomeres shorten with age in most human somatic cells, and while their initial length pre-determines cellular lifespan, the exact nature of factors establishing telomere length set point remains elusive. We will elucidate the genetic and epigenetic architecture of telomere length control and uncover novel pathways modulating natural telomere length polymorphism using the unique biological, genomic and epigenetic resources in the genetically facile plant Arabidopsis thaliana. Because modes of telomere regulation are highly conserved between eukaryotes, our data may provide important insights into the molecular basis for variation in the predisposition to telomere-associated stem cell, cancer and age-related diseases among different individuals.